Structure-function analysis of ALX4 disease alleles

PROJECT SUMMARY/ABSTRACT
ALX4 (Aristaless-like homeobox 4) is a conserved homeodomain transcription factor important for bone, skull, and limb
development. Mutations in ALX4 cause the autosomal dominant disease parietal foramina 2 (PFM2) and the autosomal
recessive disease frontonasal dysplasia 2 (FND2), and autosomal dominant variants in ALX4 are associated with an
increased risk for craniosynostosis 5 (CRS5). Despite its important role in development and association with rare human
diseases, ALX4 is an understudied protein with limited biochemical/cellular, biophysical, and structural characterization,
which limits our understanding of ALX4 function under normal physiological and human disease contexts, such as PFM2,
FND2, and CRS5. The overall goal of this proposal is to purify and characterize WT and disease associated ALX4 variants
using (1) X-ray crystallography to solve its high-resolution structure, (2) biochemical/biophysical approaches, such as
electrophoretic mobility shift assays (EMSAs) and isothermal titration calorimetry (ITC), to analyze its binding interactions
with DNA, and (3) luciferase assays to assess their transcriptional regulatory properties. Our preliminary data supports the
hypothesis that these variants negatively affect ALX4 interactions with DNA and/or cooperative binding, which underlies
the pathophysiologic basis of these variants in PFM2, FND2, and CSR5. To test our hypothesis and achieve our goal, we
will pursue the following two experimental aims – Aim1: Purify and determine high-resolution structures of ALX4 and
Aim2: Characterize the DNA binding and regulatory properties of WT ALX4 and disease variants. Completion of this
proposal will provide a deeper understanding of ALX4 structure and function for both WT and disease associated variants
that map to its HD. Moreover, completion of this pilot project grant will lay the groundwork for subsequent collaborative
studies that characterize ALX4 function in human development and disease using a multidisciplinary approach, combining
structural and in vitro biophysical and biochemical/cellular studies with organoid and mouse models of ALX4.

Public health relevance
PROJECT NARRATIVE ALX4 is a transcription factor that is important for proper bone, skull, and limb development, and mutations in ALX4 are associated with several different human birth defects that affect the development of the face, skull, and limbs. The overall goal of this proposal is to determine high-resolution structures of ALX4 and use biochemical/cellular assays to understand how ALX4 disease associated variants affect its function. Completion of these studies is important for understanding ALX4 function under normal physiological and pathophysiological contexts and will lay the groundwork for future studies to study ALX4 using in vivo models and initiate drug discovery projects focused on ALX4.